Treatment of isoniazid-resistant tuberculosis: closing evidence gaps on safety, effectiveness, and pharmacokinetics of the standard regimen

PROJECT SUMMARY.
Tuberculosis (TB) is a dangerous disease that, prior to the advent of COVID-19, was the leading cause of death
from an infectious agent. M. tuberculosis resistance to anti-TB drugs worsens clinical outcomes and poses a
serious threat to global TB control. Resistance to isoniazid, the first-line drug with the most potent early
bactericidal activity, is the most common form of resistant TB and reduces the efficacy of standard 6-month
treatment. Based on a meta-analysis of observational reports, the WHO, the US CDC, and several scientific
societies, have recommended an alternative regimen for isoniazid-mono-resistant TB that substitutes
levofloxacin for isoniazid and includes a 6-month course of levofloxacin along with rifampicin, ethambutol, and
pyrazinamide (6Lfx-REZ regimen). To date, this is a weak recommendation because it is based on evidence
rated as very low quality. It is also acknowledged that the prolonged administration of pyrazinamide entails a
considerable risk of liver toxicity, and it may be necessary to increase the dose of rifampicin and levofloxacin to
boost efficacy, within sufficient safety criteria, because it lacks the bactericidal action of isoniazid. The prevalence
of isoniazid-mono-resistant TB in Peru is significant; in Lima, 20% of TB cases are isoniazid-resistant but half of
them are still sensitive to rifampicin.
Additionally, the 6Lfx-REZ regimen is being applied across the nation following new national TB guidelines. Here,
we propose a study to fill in some of the gaps in the evidence supporting the safety, tolerability, effectiveness,
and drug dosages of this regimen. We will recruit patients in primary health care centers throughout metropolitan
Lima and use rapid molecular and phenotypic tests to identify 218 isoniazid-resistant and rifampicin-sensitive
TB participants who receive the 6Lfx-REZ regimen. Through active pharmacovigilance of these patients with
phone calls every two weeks and periodic medical examinations with laboratory tests, we will assess the safety
and tolerability of the regimen. We will measure sustained effectiveness up to 12 months post-enrollment with
periodic sputum cultures and assess the acquisition of additional resistance in individuals who fail treatment or
relapse. We will also determine pharmacokinetic (PK) and pharmacodynamic (PD) parameters of levofloxacin
and rifampicin at week 8 in a subset of participants, oversampling those who fail to convert their culture to
negative to determine the minimum inhibitory concentrations of both drugs in baseline isolates. We believe that
this study will offer useful information about the regimen used to treat the most prevalent type of drug-resistant
TB. The data will be transferable to environments with a high prevalence of resistant TB. Finally, we believe that
this prospective cohort design will provide high-quality evidence promptly while also strengthening the clinical
research capabilities of the participating Peruvian institutions.

Public health relevance
PROJECT NARRATIVE. The purpose of this research is to confirm that the current treatment regimen for isoniazid-resistant tuberculosis (the most common drug-resistant tuberculosis) is well tolerated, has few side effects, and meets the WHO recommended efficacy target (90 percent treatment success). It will also assess blood concentrations of the most important drugs in the regimen to consider making dose adjustments that improve efficacy and safety. If the regimen is safe and effective, its duration could be reduced by adjusting doses; alternatively, exposure to specific drugs could be reduced or doses adjusted to improve efficacy while avoiding safety concerns.